Cross Training Core

Cross Training Core Summary

The Cross Training Core (CTC) harnesses the proposed ROBIN to launch an interprofessional training program for the novel generation of radiation scientists (physician-scientists, biologists, physicists, and data scientists), to master immune-radiation investigations.
This program is based on the research and expertise in Radiation and Immunity from three institutions that championed multidisciplinary study of cancer. The dynamic and innovative environment of the proposed ROBIN will provide a particular fertile environment to nurture young scientists eager to broaden their training to study Radiation and Immunity. Together with the ROBIN stimulating intellectual environment, young scientists will have ample opportunities to learn from multidisciplinary key opinion leaders that are committed to provide a comprehensive and integrated interprofessional education, with the ultimate goal to facilitate cross-pollination of ideas and the training for the future generation of leaders in Radiation and Immunity.

To fill the lack of interprofessional education, an interconnected, multi-institutional, interprofessional program is necessary to connect the various components of ROBIN. By providing a CTC interprofessional educational program, ROBIN mentors, mentees, and research collaborators will meet regularly both virtually and in-person to discuss their ongoing research projects across the ROBIN group, learn from experts in the core ROBIN professions of clinical radiation oncology, medical physics, radiation/cancer biology, and immunology, and facilitate a forum for brainstorming, cross-pollination of innovative ideas. The ROBIN-CTC is the fertile ground on which to develop the next generation of leaders in Radiation and Immunity research and clinical care by connecting faculty and trainees with a strong interest in Radiation and Immunity. This global interconnected program will greatly enhance training and empower participants to leverage a network of experienced interprofessional faculty who share a common educational and research mission.

Public health relevance
The Cross Training Core (CTC) of the ROBIN initiative aims to train a new generation of interdisciplinary scientists and physicians to lead advancements in cancer treatment through the integration of radiation and immune sciences. By fostering collaboration among clinicians, biologists, physicists, and data scientists, the program addresses critical gaps in cancer research and care. Ultimately, the CTC enhances public health by accelerating both the development of innovative cancer therapies and the training of highly skilled professionals equipped to implement them.